UCLA Short-Term Research Experience to Unlock Potential (UCLA STEP-UP)

PROJECT SUMMARY/ABSTRACT
The University of California, Los Angeles proposes to serve as a Coordinating Center for the Western Region
for the NIH-NIDDK NIDDK Short-Term Experience Program to Unlock Potential (STEP-UP) Program. The
UCLA STEP-UP will provide an enriched summer research experience for promising high school students from
underrepresented racial/ethnic minority (URM) groups as well as students from other groups underrepresented
(URG) in medicine and science. The overarching goal of the UCLA STEP-UP is to prepare participating
students for research careers in the biomedical and clinical health sciences.
The paucity of participation from URM and URG communities in the scientific research workforce is a critical
limitation affecting the future of health research, and ultimately our nation’s health. Access to a high-quality
biomedical science education required for a research career remains largely influenced by factors such as
socioeconomic class, race/ethnicity, gender and/or national origin. There is a critical need to motivate and equip
URM and URG high school students with the requisite skill set to critically understand, explore and engage in
scientific research, as well as the confidence and communication skill set required for advancement in scientific
careers. Early interventions in the high school education timeline can help to build a diverse and inclusive
scientific workforce. The Program’s main components include: 1) Understanding responsible conduct of
research, 2) Exposure to scientific research environments, 3) Developing relationships with research mentors, 4)
Basic statistics, 5) Use of common laboratory equipment, 6) Development of a research abstract, 7) Lessons in
health disparities, and how biomedical research can improve health outcomes, 8) College planning, 9) Research
presentation skills, and 10) Scientific career exploration. The Program’s overarching goal is to increase the
number of URM and URG high school students prepared to pursue careers in NIDDK mission area related
biomedical and clinical health sciences. To this end, the Specific Aims are as follows:
Specific Aim 1: To engage 25 URM or URG high school students in the US Western Region each year in a
mentored, summer scientific research experience in basic, clinical, or translational research related to conditions
within the NIDDK mission.
Specific Aim 2: To provide 25 URM or URG high school students each year with an end of program
opportunity to present written reports and PowerPoint presentations based on their summer research projects at
the annual NIDDK STEP-UP research symposium on the NIH campus in Bethesda, Maryland.
Specific Aim 3: To evaluate the effectiveness of the UCLA STEP-UP to prepare 25 URM or URG high school
students each year to conduct biomedical research, engage with research mentors, produce a scientific
presentation, enhance their desire to pursue and successfully graduate with a STEM undergraduate major, and
pursue graduate programs in a science-related field focusing on NIDDK mission areas.

Public health relevance
PROJECT NARRATIVE The University of California, Los Angeles proposes to serve as a Coordinating Center for the Western Region for the NIH-NIDDK NIDDK Short-Term Experience Program to Unlock Potential (STEP-UP) Program. The UCLA STEP-UP will provide an enriched summer research experience for promising high school students from underrepresented racial/ethnic minority groups as well as students from other groups underrepresented in medicine and science. The overarching goal of the UCLA STEP-UP is to prepare participating students for research careers in the biomedical and clinical health sciences.